Core Research Services for Molecular Imaging and Imaging Sciences

The core facilities support translation research in the imaging sciences. Radiology and Imaging Sciences has evolved over the years. Supporting imaging research with core facilities and training academic radiologists and imaging scientists in the Intramural Program is the main goal. The Laboratory for Diagnostic Radiology Research has evolved into a more broad program for core support of translational research related to Radiology and Imaging Sciences, maintaining infrastructure for core basic science lab facilities in Radiology with biology, molecular biology bays, synthetic chemistry bays, in vivo and ex vivo microscopy, BSL 2 and BSL 3 tissue culture rooms, cold rooms, laser capture, confocal microscopy, in vivo microscopy, contrast agent development, stem cell trafficking, cell migration, nanoparticle analysis and characterization, integrin antagonist synthetic chemistry, multi-modality probes, atherosclerosis probes, molecular imaging of colonic polyps, multi-modality imaging, molecular interventions, and liposomal chemistry. The core facility has recently added a microPET/microCT facility for imaging rodents who have been injected with PET tracers as part of experimental studies. There is a variety of shared equipment and facilities in the department that supports Radiology and Imaging Sciences Investigators and collaborative Intramural Investigators and labs, as well as the training of junior clinical, translational and basic science investigators.